Administrative Core

Frontotemporal degeneration (FTD) is an understudied clinical neurodegenerative condition. Nevertheless, this
is the most common dementia after Alzheimer disease (AD) in people younger than 65. The most common
pathology associated with dementia in FTD is frontotemporal lobar degeneration (FTLD) due to transactive
DNA binding protein of ~43 kD (TDP-43), known as FTLD-TDP. FTLD-TDP pathology is also found in ALS and
many other conditions associated with aging including Limbic-predominant Age-related TDP-43
Encephalopathy (LATE). Since our discovery of FTLD-TDP in human disease, major gaps in understanding the
pathophysiology and spread of human FTLD-TDP pathology and poor antemortem identification of patients
with dementia due to TDP-43 pathology have been immense impediments to developing disease-modifying
treatments that aim to target this pathology. In this Program Project Grant (PPG), we propose a novel and
unique multidisciplinary research program focused on elucidating pathophysiologic mechanisms of human
TDP-43 pathology, identifying FTLD-TDP in vivo in dementia and aging, and understanding the clinical
consequences of FTLD-TDP pathology. With greater insight into mechanisms of disease associated with TDP-
43 pathology, translational work will fill major gaps in in vivo diagnosis and prognosis. Administrative Core A is
designed to provide administrative support including regulatory and financial management for the scientific
work proposed by the five Projects and four Cores of this PPG, coordinate the interaction of these
multidisciplinary Projects and Cores through an Internal Executive Committee (IEC) consisting of the Project
Leaders (PLs) and Core Leaders (CLs), ensure that annual goals are maintained with guidance from an
External Advisory Committee (EAC) of experts together with NIA staff, disseminate and coordinate our work
with other scientists at and beyond University of Pennsylvania (Penn), engage young scientists in research
investigating TDP-43, and disseminate knowledge to patients and families who have FTLD-TDP-related
disorders. We achieve these goals through seven Specific Aims.